Infections and Drug Use-Related Morbidity and Mortality among People Who Use Drugs

PROJECT ABSTRACT
Bacterial and fungal infections associated with drug use are increasing substantially in the United States. Two
such infections, skin and soft tissue infections (SSTI) and infective endocarditis (IE), can lead to significant
illness or death among people who use drugs (PWUD). SSTIs, such as abscesses and cellulitis, are highly
prevalent with up to 65% of people who inject drugs reporting recent SSTIs. IE is an infection of the heart that
typically requires long-term hospitalization. In addition to these infections, some PWUD face other pressing
health concerns, most notably opioid use disorder and overdose. Infection-related mortality may be a
substantial contributor to all-cause mortality among PWUD. However, from a population perspective, little
is known about the determinants and burden of infection-related mortality relative to drug overdose
among PWUD. Among some PWUD, opioid use disorder is a potentially serious yet treatable condition. FDA
approved medications are known to reduce opioid use disorder symptoms and modify underlying behaviors
that may increase risk of infections and overdose, such as injection drug use. Race, ethnicity, and gender
inequities in access to and use of medication for opioid use disorder (MOUD) exist, and the role of
intersectionality of these identities in MOUD access or use are not known among those receiving care for
infectious diseases. The overall objective of this proposal is to expand the knowledge base concerning
infection-related mortality, fatal and nonfatal drug overdose, and all-cause mortality in PWUD diagnosed with
SSTIs and IE, with a particular focus on opioid use disorder. Primarily, the project will document the burden
and predictors of infection and drug overdose mortality among PWUD with a particular focus on those facing
these infections. Additionally, we will quantify the effect of MOUD on increasing survival and improving health
outcomes in PWUD with SSTIs and IE. Finally, the project will examine disparities in MOUD by race, ethnicity,
and gender. The project will utilize an extensive dataset of healthcare records for over half of North Carolinians
linked with death certificate data. The specific aims of this study are to (1) assess predictors of infection-related
mortality and drug overdose among PWUD, (2) estimate the effect of MOUD on infection-related mortality and
drug overdose mortality among PWUD diagnosed with SSTIs or IE, and (3) examine receipt of MOUD and
continuation among PWUD diagnosed with SSTIs or IE by race, ethnicity, and gender. Accompanying the
proposed research, a specialized training plan for the principal investigator will enhance her skill set in: (1)
study design of drug use-related health outcomes, (2) robust methodological approaches to the use of
administrative data in translational research, and (3) professional development and research dissemination in
scientific and community settings. Through the proposed research and mentorship from a multidisciplinary
team, the principal investigator will undertake a specialized training program that will lay the foundation for a
career as an independent researcher in the areas of substance use epidemiology and translational research.

Public health relevance
PROJECT NARRATIVE Infections associated with drug use profoundly impact morbidity and mortality in people who use drugs. Results from this study will enhance our limited understanding of outcomes resulting from infections associated with drug use. The study will help inform comprehensive public health strategies, such as harm reduction interventions and expansion of access to medication for opioid use disorder, to improve the health and well- being of people who use drugs.